COLLABORATIVE PROSPECTIVE STUDY OF VERTICAL TRANSMISSION OF HIV

Women and Infants Transmission Study (WITS), the purpose of which is to begin to understand how often HIV is passed on to children of risk mothers; to make early diagnosis; to understand how children with HIV infection grow and develop; and to allow early intervention as therapies become available. A number of findings over a broad spectrum of disciplines has begun to emerge from the WITS study. The preliminary findings are interesting and may possibly be useful for counseling pregnant women.